Skeletal Muscle Stem Cells in Development, Regeneration, and Adaptations

PROJECT SUMMARY
This application seeks partial support for the upcoming Society for Muscle Biology (SMB) conference entitled,
"Skeletal Muscle Stem Cells in Development, Regeneration, and Adaptations", which will be held July 14-19,
2024 in Esterel, Quebec, Canada. This will be the 12th edition of this conference focusing on skeletal muscle
stem cells (MuSCs) and the 1st sponsorship by SMB. This biennial meeting has traditionally been operated by
FASEB, but we decided to run the 2024 conference under SMB to allow the organizers and participants more
autonomy. This change lends to a more robust and vibrant SMB, which will focus on providing more support for
trainees. We expect approximately 130 attendees from around the world of whom ~50% are expected to be
women and ~60% junior researchers. No other scientific meeting has a primary focus on MuSCs. The need for
a conference with this focus is demonstrated by the steady increase in attendance since the meeting's inception
and the consistently excellent post-meeting evaluations provided by meeting attendees. This meeting attracts all
leading MuSC researchers from around the world, further demonstrating its value for established and future
leaders in the field. The overall objectives of this meeting include: 1) to provide a comprehensive analysis of
recent discoveries in the field, with the goal of understanding the regulatory mechanisms controlling normal and
abnormal functions of MuSCs in muscle development, homeostasis, regeneration, hypertrophy, aging, and
myopathy; 2) to create and foster an interactive environment for the exchange of ideas and unpublished data,
so as to hasten discoveries and facilitate new and existing collaborations; 3) to provide opportunities for junior
investigators to present their work and network with senior investigators; and 4) to facilitate career development
of women and other underrepresented groups by ensuring representation in all aspects of the conference
program. Our keynote speaker will be Dr. Juan Carlos Belmonte, a renowned biochemist and developmental
biologist. Scientific sessions are planned, presenting 48 speakers (24 confirmed invited speakers and at least
24 selected from submitted abstracts) at all career levels. Session topics include: (i) molecular regulation of
MuSCs, (ii) MuSC aging, (iii) MuSC transcriptional states, (iv) MuSC activation and fusion, (v) dynamics of
muscle regeneration, (vi) engineering and translating MuSCs, (vii) MuSCs and friends during exercise and
growth. Invited speakers have been selected for their scientific excellence, with particular attention to equal
representation of women and minorities and geographical diversity. Speakers are explicitly required to present
unpublished work, to ensure scientific discussion is at the forefront of the field. We will have poster sessions,
each preceded by a “posters blitz” where poster presenters will give a one-minute talk to highlight their work;
career-oriented workshops and “meet-the-speaker” breakfast and lunch sessions. This meeting will provide a
forum to foster discussion and cross-fertilization from diverse areas of research, to advance our understanding
of muscle regeneration and aid in the development of therapeutics.

Public health relevance
PROJECT NARRATIVE Skeletal muscle stem cells, also known as satellite cells, are responsible for the remarkable regenerative properties of skeletal muscle and are of very high interest to the scientific community as their study has produced major insights into muscle biology and stem cell behavior generally. This conference, the only one dedicated to this topic, will bring together international leaders in the field, as well as graduate students, postdoctoral researchers, junior faculty, and stem cell biologists from other systems to present and discuss unpublished work in this fast-moving, cutting-edge field. Therefore, this conference has high relevance for human health, as these advances and new ones that will proceed from them will drive work in muscle growth, repair, disease and aging.